Administrative Core

ABSTRACT – Administrative Core
The purpose of this Collaborative Program is to bring together investigators focusing on a coordinated and
synergistic strategy within the overarching goals of the Nonhuman Primate Transplantation Tolerance
Cooperative Study Group (NHPCSG), including: (1) development of novel tolerance induction regimens; (2)
evaluation of the preclinical safety and efficacy of existing and newly developed candidate immune tolerance
induction regimens; (3) development and validation of biomarkers for the induction, maintenance and/or loss of
immune tolerance or for the prediction of graft rejection; and (4) elucidation of the mechanisms underlying the
induction, maintenance, and/or loss of tolerance in NHP allograft models of islet, kidney, heart, and/or lung
transplantation. In order to coordinate our program’s efforts to achieve these goals, we propose an Administrative
Core to manage fiscal and other resources, facilitate interactions and communication, ensure timely progress
toward program goals, and ensure adherence to NIH regulations regarding management of the grant.